Developmental Pilot Projects

The overall goals of the Pilot Project Program are to 1) provide seed funding for novel, creative and high risk research projects, 2) promote interdisciplinary research programs, 3) spark the interest of individual faculty members, and 4) provide a mechanism for merit based distribution of development funds. Availability of this funding mechanism has had a significant impact in developing novel technologies, advancing research tools from bench to bedside and discovering important aspects of tumor biology through in vivo imaging. In the past, this type of funding mechanism has led to significant discoveries in our Center, for example, enzyme activatable imaging probes, magnetic cell tracers or tyrosinase constructs to image gene expression. The specific aims are: 1. Continue a successful Pilot Project Program and fund 2-4 novel projects per year 2. Provide clerical and administrative support to the projects.